Outer Segment tip ingestion by the RPE

Project Summary
An important function of the retinal pigment epithelium (RPE) is to ingest and degrade outer segment (OS)
disk membranes from the photoreceptor cells. This catabolic role in the turnover of the phototransductive
disk membranes is essential for the viability of the photoreceptor cells, with defects in the underlying
processes leading to retinal pathogenesis. The proposed research focuses on the first event: the ingestion of
the OS tips. We have developed high-speed live-cell imaging of this dynamic process by primary RPE cells.
3D analyses show that following formation of an f-actin cup around the OS tip, transient foci of actin filaments
form at the site of scission of the OS, indicating that OS tip ingestion occurs by trogocytosis, involving
dynamic polymerization of actin. The first two specific aims will combine studies on primary RPE cells in
culture and in vivo analyses to investigate molecular mechanisms associated with the actin polymerization in
this ingestion. The third aim addresses the daily timing of OS tip ingestion by performing experiments in
which this event can be quantified by isolating it from the effects of phagosome degradation on phagosome
number. The proposed experiments challenge current assumptions about how the OS tips are ingested by
the RPE, and the daily timing of this cellular process. They are expected to generate novel findings that will
establish a more accurate fundamental understanding of mechanisms underlying OS tip ingestion.

Public health relevance
Project Narrative The proposed research will provide a fundamental understanding of cellular mechanisms and the daily timing of the ingestion of the tips of the photoreceptor outer segments by the retinal pigment epithelium (RPE). The RPE is essential to retinal function and health, and defects in this specific ingestion process are included as causes of retinal degenerations. Hence, the studies described in the current application will elucidate a key function of the RPE and provide a scientific framework for developing disease therapies.